Center for Translational Pediatric Research

Project Summary
Parent award. The parent award for this supplement is associated with the Arkansas Children's Research
Institute (ACRI) Center for Translational Pediatric Research (CTPR: P20GM121293-05S1). The CTPR aims to
build an innovative, multi-disciplinary pediatric research center that utilizes cutting-edge systems biology
technologies and state-of-the-art translational research to study pediatric diseases. The COBRE Administrative
Supplement NOSI supports the development of team science projects that bring together… investigators
from IDeA states with different perspectives and expertise to address complex, clinical and/or translational
research questions with complementary approaches. These goals are in lockstep, and this proposal utilizes team
science approaches from investigators with a history of successful collaborations from two IDeA states.
The current proposal is directly in line with the goals of the CTPR and is headed by one current and two former
COBRE-funded investigators from two IDeA states. The overall objective of the Pediatric Acute Respiratory
Infection Study (PARIS) is to conduct a comprehensive genomic assessment of current circulating respiratory
viruses and compare those to viruses collected since 2015 to elucidate the clinical impact of viral genetic diversity
and the geographic and temporal distribution of respiratory virus strains and how respiratory viruses change
throughout the seasons and over multiple years.
Research question. Respiratory infections cause approximately 2 million global deaths each year. As was seen
during the COVID-19 pandemic, different genetic strains of the same virus may have varying levels of virulence
and clinical manifestations. Differentiating and determining these factors during clinical presentations is crucial
for all respiratory viruses. This supplement aims to differentiate and determine the clinical impact of viral genetic
diversity, distribution, and seasonal variations of respiratory viruses, expanding our knowledge beyond SARS-
CoV-2. By sequencing and comparing historical and current viral samples, we will provide actionable information
on transmission patterns, genomics, phylogenetics, and epidemiology of respiratory viruses to clinicians. Further,
we will compare Electronic Health Records data from Arkansas and New Mexico to classify the severity of clinical
outcomes using the World Health Organization's Ordinal Scale for Clinical Improvement and based on the
isolated viral variant.
Team science approach. We represent a collaboration between clinicians, genomic scientists, and
epidemiologists. Dr. Kennedy is an Allergy and Immunology clinician at Arkansas Children's Hospital and ACRI,
who has extensively studied the role of respiratory infections causing asthma exacerbations. Dr. Dinwiddie is an
expert in respiratory viruses and human genomics and has over fifteen years of experience designing,
developing, and implementing next-generation sequencing protocols, including in a CAP/CLIA-approved
environment. Dr. Domman is a microbiologist, bioinformatician, and genomic epidemiologist who has published
extensively on the use of sequence data to understand the transmission of infectious diseases. Together, we
each bring expertise that, when combined in the form of team science, enables a robust and extensive study to
investigate the role of genomic and temporal variation of respiratory viruses in the clinical outcomes of pediatric
respiratory infections.

Public health relevance
Project Narrative This proposal aims to conduct a comprehensive genomic assessment of respiratory viruses, comparing historical and current samples to determine the clinical impact of viral genetic diversity, distribution, and seasonal variations. The study will provide actionable information on transmission patterns, genomics, phylogenetics, and epidemiology of respiratory viruses in children. The collaboration between a clinician, a genomic scientist, and an epidemiologist/bioinformatician enables a robust team science approach to investigate geographic and temporal variations of respiratory viruses and how these variants impact clinical outcomes in children.